Tryptophan metabolism in Haemophilus persistence and formation of intracellular communities

Abstract
Infections caused by nontypeable Haemophilus influenzae (NTHI) strains represent a major cause of otitis media
(OM), exacerbations of chronic obstructive pulmonary disease (COPD), and bacterial sinusitis. Furthermore,
NTHI causes chronic, treatment-refractory diseases, in part by forming intracellular bacterial communities (IBCs)
within epithelial cells that provide a refuge from both the host immune system, and from clinical interventions.
The bacterial and host elements that impact NTHI persistence and recurrence of OM are not completely
understood. Therefore, the delineation of host-pathogen interactions and metabolic influences that lead to OM-
derived sequelae will inform novel therapeutic approaches. Our prior studies revealed a significant increase in
all tryptophan biosynthetic pathway proteins during biofilm growth of a persistent isolate of NTHI. This isolate
also demonstrated a significant increase in IBC formation during experimental OM. Critical to host-pathogen
interactions is modulation of tryptophan levels. Tryptophan biosynthesis promotes intracellular survival of other
pathogens and degradation of host tryptophan limits bacterial growth. In this study, we will delineate the
contribution of tryptophan metabolism to NTHI pathogenesis during OM. Our central hypothesis is that NTHI
adaptation to nutrient stress enhances invasion, IBC formation, persistence and recurrence. Our published
studies indicate that multiple aspects of metabolism contribute to NTHI IBC formation and persistence. Our
approach is to Determine the contribution of tryptophan metabolism in NTHI persistence and IBC
formation (Aim 1). We hypothesize that bacterial adaptation to nutrient limitation modulates NTHI tryptophan
biosynthesis that directly impacts pathogenesis and persistence. We will also evaluate the efficacy of
interference with tryptophan biosynthesis as a novel therapeutic target (Aim 2). We hypothesize that
prevention of invasion of NTHI into epithelial cells will promote bacterial clearance and thereby reduce the
potential for recurrence of OM. Our studies will reveal mechanisms of tryptophan acquisition on NTHI behaviors
that correlate with host responses during OM. Exploitation of these pathways to mitigate IBC development will
provide a platform to continue to develop combinatorial treatments that target both the extracellular and
intracellular populations of NTHI as an advanced therapeutic option to treat clinical disease.

Public health relevance
Project Narrative Nontypeable Haemophilus influenzae (NTHI) causes otitis media and often facilitates persistent or recurrent infections in children. In order to cause disease, NTHI must adapt to the physiological environment of the host. We will monitor the effect of tryptophan metabolism on NTHI invasion and host responses, to provide insight into the role of NTHI in recurrence and identify new targets for development of therapies to treat this common childhood disease.